National Cell Repository for Alzheimer's Disease (NCRAD)

7. PROJECT SUMMARY/ABSTRACT The National Cell Repository for Alzheimer's Disease (NCRAD) plays a key role in the National Institute on Aging's (NIA) efforts to identify those at risk for Alzheimer disease (AD) and develop improved treatments to delay or prevent disease onset. NCRAD was established as a cooperative agreement with the NIA to serve as the biospecimen core for all NIA-funded dementia studies. Under the advisement of NIA and the NCRAD Executive Committee (NEC), it is the mission of NCRAD to remove critical barriers hindering research progress to understand the etiology of dementia. To achieve this goal, NCRAD has two primary functions: sample banking and sample distribution. This application is in response to a request by NIA to continue the support for NCRAD (PAR-15-316). NCRAD will work closely with other national efforts in AD research to achieve the following specific aims: Aim 1: To provide a state-of-the-art central biospecimen repository for all NIA-funded dementia studies. Aim 2: To facilitate and foster sample sharing to all qualified investigators.

Public health relevance
8. PROJECT NARRATIVE This application proposes to renewal the National Cell Repository for Alzheimer Disease (NCRAD), an NIA funded repository for dementia-related studies. NCRAD will work closely with NIA, studies banking samples, as well as researchers requesting samples to ensure that the biospecimens banked at NCRAD are of the highest quality. These biospecimens will be used to perform research with the ultimate goal of developing new treatments for Alzheimer disease and other types of dementia.